Mechanisms of Variability in the Analgesic Response to Ibuprofen Following Third Molar Extraction

PROJECT SUMMARY/ABSTRACT
Nonopioid analgesics are highly effective for pain management following most dental procedures, but data
suggest that prescription of opioids by dental clinicians is excessive. Prescription opioid misuse remains a
significant public health concern in the US, and ongoing opioid crisis has highlighted the need to optimize pain
management with non-addictive analgesics, with non-steroidal anti-inflammatory drugs (NSAIDs) at the forefront.
Numerous clinical trials have shown that NSAIDs are effective in the treatment of post-surgical pain following
third molar extraction. However, there is substantial inter-individual variability in the analgesic response, with
20-30% of patients requiring opioids in addition to NSAIDs to achieve adequate pain relief. The use of precision
medicine approaches to tailor analgesic therapy would enable oral surgeons to rationally prescribe opioids to
only those patients who require them and avoid unnecessary opioid prescriptions in those patients who can
achieve adequate pain relief with NSAIDs alone. However, the factors that contribute to heterogeneity in
analgesic response to NSAIDs and need for opioid rescue medication have not been well-studied, and there is
limited evidence to inform which patients should receive opioid prescriptions and how much should be
prescribed. The work proposed in this application will identify individual host factors associated with need for
opioid analgesics, in addition to NSAIDs, following third molar extraction. We will specifically investigate the role
of inter-individual differences in regulation of the acute inflammatory response to surgical trauma and seek to
identify an inflammatory response signature associated with need for opioid following third molar extraction. We
will also investigate the role of neutrophil subtypes in mediating heterogeneity in analgesic efficacy of NSAIDs.
Elucidation of the molecular mechanisms underlying inter-individual variability in analgesic efficacy of NSAIDs
may allow the identification of biomarkers that are predictive of response, thereby facilitating a precision medicine
approach to pain management. This work will provide a foundation for future clinical interventions to better
manage pain following third molar extraction, with the goal to limit opioid prescriptions to only those patients not
likely to respond adequately to NSAIDs.

Public health relevance
PROJECT NARRATIVE Over-prescription of opioids for surgical pain has contributed at large to the opioid epidemic, so it is important to reduce opioid prescriptions for patients who will receive good pain relief with non-addictive pain relievers, like nonsteroidal anti-inflammatory drugs (NSAIDs). Numerous clinical trials of pain management after wisdom tooth extraction surgery have demonstrated that most patients experience good pain relief with NSAIDs alone, but some patients require opioids in addition to NSAIDs. The goal of this project is to identify the factors that contribute to the need for opioid after wisdom tooth extraction to help limit unnecessary opioid prescriptions in patients who will have good pain relief with NSAIDs alone.